Novel molecular therapeutics for cystic fibrosis

DESCRIPTION (provided by applicant): Cystic fibrosis (CF) leads to chronic illness, disability, and early death. Recurrent pulmonary infections are lethal owing to growth of bacteria and other microorganisms in the abnormally viscous mucus. Antibiotics, mucolytics, and anti-inflammatory agents, are useful only in treating some CF effects. Recently, however, ivacaftor (a.k.a. VX-770 or Kalydeco), which addresses the underlying cause of CF, was approved by the FDA. Unfortunately, it is ineffective in a majority of patients. The underlying cause of CF is a mutatio of the cystic fibrosis transmembrane conductance regulator (CFTR), which normally localizes to the cell membrane and controls salt levels. In CF, a mutation decreases the amount or activity of CFTR, and the resultant salt dysregulation leads to CF pathologies. The primary mutation (> 90% in the US and ~75% worldwide) is ΔF508, deletion of a single phenylalanine residue in CFTR. ΔF508 causes improper folding of CFTR, most of which is degraded in the endoplasmic reticulum (ER) and does not reach the cell membrane. CFTRΔF508 is partially functional if it can be localized to the membrane, and corrector drugs such as VX-809/lumacaftor are being developed to promote trafficking of mutant CFTR to the cell surface. Additional ways of increasing the levels, trafficking, and/or functionality of CFTRΔF508 are being sought by intervening in various cellular pathways that regulate proteins, including the ubiquitin/proteasome pathway. Misfolded CFTRΔF508 is ubiquitylated by the ubiquitin E3 ligase gp78 and degraded via ERAD (endoplasmic reticulum associated protein degradation), decreasing its cellular level. Knockdown of gp78 leads to dramatically increased levels of CFTRΔF508 in cells and increases chloride transport. Thus gp78 inhibition should increase the amount of CFTR at the cell surface and may be useful alone or combined with correctors such as VX-809. In phase I, small molecule inhibitors of gp78 were identified and their ability to increase levels of functional CFTR, as judged by cellular assays, demonstrated. One of these hits (GP1) increased the level of core glycosylated CFTRΔF508 and, when combined with VX-809, increased the level of functional CFTRΔF508 in cells, providing further validation of gp78 as a target for the treatment of CF. In Phase II, GP1 and additional hit compounds will be improved by medicinal chemistry optimization, analyzed by in vitro and cell-based secondary assays, and tested in animal models for drug metabolism/pharmacokinetic properties, with the goal of identifying potent and selective lead compounds with efficacy as therapeutic agents for cystic fibrosis.

Public health relevance
PUBLIC HEALTH RELEVANCE: A salt regulating membrane protein, CFTR, is mutated in cystic fibrosis, producing its symptoms; the mutated protein has partial activity but because it is misfolded it is largely degraded in the cell. The proposed Phase II project entails the preclinical development of small molecule inhibitors of gp78, an enzyme responsible for the degradation of mutated CFTR. These inhibitors were identified and characterized in Phase I; one of them in particular was shown to exert the predicted therapeutic effects in cell models.